Shared Resources Management

SHARED RESOURES MANAGEMENT – ABSTRACT
The mission of the University of Hawai`i Cancer Center (UHCC) is to “reduce the burden of cancer through
research, education, patient care and community outreach with an emphasis on the unique ethnic, cultural and
environmental characteristics of Hawai`i and the Pacific”. This mission encompasses research on the
underlying biological, social and behavioral causes of cancer incidence, mortality and disparities, and on the
strategies and treatments to address them. Availability of and access to resources for laboratory analysis, data
acquisition, study design, and data analysis are essential for this undertaking. However, few of these services
are readily available in Hawai`i due to its small size and geographic isolation. Therefore, it is crucial that UHCC
provides these essential services locally. Shared Resources (SRs) were established at the UHCC to address
this mission by providing the necessary expertise, equipment, and services. Specifically, the SRs meet the
needs of the research endeavors of the Cancer Biology and Population Sciences in the Pacific Programs.
The Shared Resources proposed for support from the CCSG include 4 existing SRs, namely, Analytical
Biochemistry, Biostatistics, Genomics and Bioinformatics, and Nutrition Support, and one developing
SR, the Body Composition Lab. The goal of the Shared Resource Management is to ensure that the UHCC
Shared Resources align with the institution's mission by meeting the needs of the researchers, providing equal
access to all UHCC researchers, running cost-effectively, and offering quality state-of-the-art products. The
Shared Resource Management is administered through the Associate Director for Shared Resources and
implemented through the Shared Resource Directors. The SR Directors meet regularly to share updates and
solicit feedback. The Shared Resources are additionally guided and reviewed by an Oversight Committee of
UH faculty members. The SR directors and staff participate in community outreach and engagement (COE),
cancer research training (CRT), and diversity, equity and inclusion (DEI) efforts. The Specific Aims of the
Shared Resources are:
1) Provide research support through scientific expertise and technology to the UH Cancer Center Members,
2) Evaluate the usage, satisfaction levels, and need for current and potential new services offered through the
UHCC Shared Resources, and
3) Contribute to the training of investigators, staff, and students in research tools and technologies that will
enhance their research endeavors.